The effects of telepractice technology on dysarthric speech evaluation

Project Summary/Abstract
With telepractice becoming an increasingly popular, indeed necessary, alternative to clinic visits, speech-
language pathologists (SLPs) evaluate speech that is audio captured and transmitted remotely via a
teleconferencing solutions (e.g. Zoom). All popular teleconferencing applications use speech compression
algorithms based on linear predictive coding (LPC) to reduce bandwidth required for speech transmission. LPC
compression algorithms decompose speech into phonatory source and articulatory filter parameters, which are
then independently vector quantized and temporally smoothed based on schemes that have been developed
and optimized for compressing speech sampled from the general population. In this way, speech is transmitted
with the least number of audible artifacts and the highest level of intelligibility for the given internet connection
constraints. Because LPC algorithms are optimized using large corpora of typical speech, they are
fundamentally not well-suited for faithfully transmitting the amount of distortion or noise commonly present in
the dysarthric speech signal, and articulation and voice features are particularly vulnerable to corruption. In this
proposal the aim is to systematically characterize the impact of speech compression algorithms commonly
used in telepractice platforms on speech intelligibility, perceptual evaluation, and acoustic measurement. This
is done via two aims:
SA1: Evaluate the effects of teleconferencing speech compression algorithms at three internet
bandwidth levels on the perceptual and acoustic assessment of dysarthric speech
Existing high-fidelity audio recordings of words and sentences and sustained phonations from 20 speakers with
various dysarthrias will be encoded at three compression rates to simulate low-, moderate-, and high-
bandwidth internet connectivity. Twenty SLPs will transcribe the samples to attain intelligibility measures for the
original and encoded words and sentences; and perceptually rate vocal quality on sustained phonations.
Acoustic measures of articulation and voice will be extracted. Within-subject statistical models will evaluate
impact of bandwidth condition on perceptual and acoustic outcomes within speech tasks.
SA2: Compare outcomes for dysarthric speech recorded in a telepractice session (compressed) versus
that recorded simultaneously in-person via smartphone application (uncompressed).
Fifteen speakers with dysarthria will participate in simulated telepractice speech assessments administered by
SLPs. Subsequently, recordings from session (compressed) and simultaneously recorded in-person samples
(uncompressed) will be scored by SLPs. In-person recordings will also be compressed as in SA1 conditions.
Acoustic metrics will be extracted from all samples. Within-subject statistical models will evaluate sample
differences across conditions (uncompressed, compressed during telepractice, and low- moderate- and high-
bandwidth compression levels). Results will inform the limits of telepractice for dysarthria evaluation.

Public health relevance
Project Narrative With telepractice becoming an increasingly popular alternative to clinic visits, there is a pressing need to understand the impact of speech compression technology in telecommunications on a Speech Language Pathologist’s (SLP) ability to measure clinically-relevant outcomes. This proposal seeks to quantify the potential range of clinical impact of this technology by comparing the difference in intelligibility, perceptual dimensions, and acoustic measures in uncompressed speech relative to compressed speech. Results of these studies will provide the first tranche of evidence to inform the limits of telepractice solutions that employ speech compression for dysarthria evaluation.